MULTIMEDIA BREAST CANCER EDUCATION KIOSKS FOR LATINAS

DESCRIPTION (adapted from the applicant's abstract): Delivering breast cancer screening messages to low-income, low-literacy Latinas presents unique challenges. Interactive multi-media technologies may offer an innovative, effective, and cost-accessible medium for reaching this population. The specific aims of this Phase II SBIR research are to: 1) design culturally, linguistically and age-appropriate breast cancer education models for low-education, low-literacy Latinas using the message-development model validated in Phase I; 2) design and develop prototype kiosks that employ touchscreen and CD-ROM technologies into a device that enables users to easily navigate and control the direction and pace at which they obtain information; and 3) field test the interactive multi-media kiosks to determine their efficacy in providing breast cancer screening information to Latinas. A pre/post design will determine message effect knowledge gain, attitudinal change, self- efficacy and behavioral intent on 1600 Latina users of multi-media kiosks. Three hundred of these randomly assigned women are interviewed four months after exposure to determine behavioral change. Site assistants will conduct pre- and post interviews; the kiosks will also provide tracking data on use patterns for each information module. There are considerable opportunities for technological innovation making use of multimedia kiosks for health education. PROPOSED COMMERCIAL APPLICATION: Proposed commercial application not available.